Preventing Depression of Chinese American Adolescents through Mobile Health Application

Preventing Depression of Chinese American Adolescents through Mobile Health Application
Project Summary/Abstract
Chinese American adolescents (CAAs), traditionally perceived as a model minority, experience serious
acculturative stress and depression, with the highest rates of suicide ideation and race-related stress and
depression. These mental health problems, coupled with cultural barriers to mental health care due to stigma,
constitute a major mental health disparity. Recent discrimination against Chinese Americans since the
COVID-19 pandemic has exacerbated CAAs’ distress. This proposal addresses the disparity by developing
a new mobile health application (MHA) RRE (Relax, Reflect, Empower) to provide a culturally tailored,
personalized, and interactive prevention to reduce CAA depressive symptoms and improve their
psychological wellbeing. The proposed RRE will build upon our previous work and integrate theoretical
concepts of Mindfulness-Based Cognitive Therapy and Critical Consciousness. Aim 1. Develop RRE for
CAAs. To develop a culturally and developmentally tailored prevention for CAAs, we will apply the ecological
validity framework by soliciting input from 20 CAAs (balanced by gender, age, acculturation level, and SES)
at all stages of the RRE development for cultural and age appropriateness in language, persons, contents,
concepts, methods, contexts, and design. In consideration of within-group diversities, the RRE will be
personalized to help CAAs generate their own strategies to prevent depression. We will collaborate with the
Florida Center for Interactive Media to develop RRE and have six CAAs test RRE functionality and usability
and provide feedback for improvement. To Examine Preliminary Efficacy of RRE, we will conduct a pilot
study of a community sample of 110 CAAs, ages 14-18. We will use adaptive randomization to assign 55
participants to RRE for 5 days/week for 3 months and 55 to the control group who will receive a weekly
wellness check-in text message for 3 months. Aim 2. Evaluate Feasibility and Acceptability. Assessments
include both subjective (CAAs’ responses on feasibility and acceptability of RRE through Mobile Application
Rating Scale and open-ended questions) and objective (CAAs’ frequency and duration of RRE access
automatically recorded) measures. Aim 3. Investigate CAAs’ Changes in Depressive Symptoms, Coping
Self-Efficacy, and Psychological Wellbeing. Participants in both RRE and control groups will complete
measures of outcomes (depression, coping self-efficacy, psychological wellbeing) and influencing factors
(acculturative stress, experiences of discrimination, life events) at three time points: baseline, the end of 12th
week and 16th week. We expect CAAs in RRE group to exhibit lower levels of depressive symptoms and
higher levels of coping self-efficacy and psychological well-being than the control group at Weeks 12 and 16.
Additionally, CAAs in the RRE group will exhibit greater improvement than the control group in the outcome
measures from baseline to Weeks 12 and 16. The development and testing of RRE to address CAA mental
health disparities will have significant public health impact as RRE is highly scalable for other minority groups.

Public health relevance
Project Narrative Chinese American adolescents (CAAs), traditionally perceived as a model minority (i.e., smart, diligent, quiet), experience serious acculturative stress and depression coupled with cultural barriers to care and racial/cultural discrimination, facing a major mental health disparity. This proposal addresses the disparity by developing a new mobile health application for CAAs to provide a culturally tailored, personalized, interactive, accessible, and economical depression prevention. The app will be highly scalable and easily adaptable for other minority groups.